A cross-national comparative study on cardiometabolic risk, education, and cognitive aging

PROJECT SUMMARY
Alzheimer's Diseases and Alzheimer's Disease-Related Dementias (AD/ADRD) impose significant
global challenges that necessitate research to identify critical protective and risk factors of cognitive health.
Research from developing countries shows that the decline in age-specific prevalence and incidence of severe
cognitive impairment and dementia since the 1980s parallels the rise in educational attainment and
improvements in the control of cardiometabolic risk (CMR). However, the complex dynamics of education,
CMR, and cognitive health complicate efforts to pinpoint specific pathways from education or CMR to cognitive
outcomes. The proposed research will use representative longitudinal data from the United States Health and
Retirement Study and its international sister studies in England, China, and Indonesia, as well as new data
obtained from the Harmonized Cognitive Assessment Protocol studies to systematically and rigorously
describe and compare the CMR and educational patterns of cognitive function, cognitive aging, and dementia
in four countries. These countries comprise about 25 percent of the world's population, are at different levels of
economic development and stages of nutritional transition, and represent a wide range of historical, cultural,
social, epidemiological, and medical contexts. This research is important because the cross-national
comparison of key patterns of cognitive health will enhance the understanding of how broad social-
environmental contexts, coupled with their embedded individual characteristics and experiences, affect
cognitive health in old age. To accomplish this research goal, the K99 phase will involve training in
neuropsychology, the international context of health and aging, and advanced techniques in comparative
analysis using longitudinal data. This training will take place at the Carolina Population Center (CPC) at the
University of North Carolina at Chapel Hill (UNC). CPC is an ideal location to receive the training necessary for
the proposed research, given the interdisciplinary nature of the CPC in terms of global studies of health and
wellbeing, and interdisciplinary mentorship, and the access to a wide range of coursework that UNC offers.
Building on the training gleaned during the K99 phase, the goal of the R00 phase will be to (1) examine the
CMR and educational patterns of cognitive aging and dementia by modeling the longitudinal relationships and
using the fixed-effect framework; and (2) contrast these patterns across countries.
Cognitive aging is a highly complex process that is influenced by factors at the individual and societal
levels. This comparative research will provide a comprehensive picture of cognitive health that cannot be
observed in more homogenous populations, enhance the understanding of ways that broad social-
environmental contexts, coupled with their embedded individual characteristics and experiences, affect
cognitive aging, and, in so doing, provide key insights that can be used to respond to the challenges posed by
AD/ADRD worldwide.

Public health relevance
PROJECT NARRATIVE Cognitive aging is a highly complex, dynamic, and context-dependent process that is influenced by factors at the individual and societal levels The proposed research will use representative longitudinal data from the United States Health and Retirement Study and its international sister studies in England, China, and Indonesia, as well as new data obtained from the Harmonized Cognitive Assessment Protocol studies to systematically and rigorously describe and compare the relationships between cardiometabolic risk and education to cognitive function, cognitive aging, and dementia in four countries. This comparative research will enhance the understanding of ways that broad social-environmental contexts, coupled with their embedded individual characteristics and experiences, affect cognitive health in old age thus providing key insights that can be used to respond to the challenges posed by Alzheimer's Diseases (AD) and Alzheimer's Disease- Related Dementias (ADRD) worldwide.